Absolute Brain Thermography using Multinuclear MRI

PROJECT SUMMARY
Stroke is the leading cause of disability, the second leading cause of dementia, and the second leading
cause of death worldwide, affecting nearly 800,000 patients per annum in the U.S. alone. Cerebrovascular
ischemia is rapidly potentiated by rising body temperatures, occurring even with mild and sub-febrile
hyperthermia. The potency of hyperthermic damage in ischemic brain arises due to impaired cooling in
hypoperfused brain tissues. Consequently, localized brain hyperthermia can precede, and commonly exceeds,
systemic temperature changes following ischemic injury, and is well-recognized as accelerating stroke
progression and consumption of at-risk tissues. Despite severe worsening of clinical outcomes among febrile
stroke patients, the development of prognostic biomarkers and robust treatment targets in peri-ischemic cerebral
hyperthermia remains unrealized due to lack of pragmatic means to acquire accurate spatially-resolved cerebral
thermographs.
MR thermometry (MRT) using the proton resonance frequency (PRF) chemical shift with 1H-MR
spectroscopy (MRS) has been explored for non-invasive cerebral thermography. Despite promising results,
several fundamental limitations undermine estimation of absolute temperature and thus impede development of
meaningful clinical paradigms, including: 1) the local environment in tissues can significantly alter performance
and affect temperature estimation; 2) magnetic field fluctuations caused by physiological- and hardware-related
noise introduce large errors in temperature estimation; and 3) low temperature sensitivity and signal-to-noise of
spectroscopic imaging approaches hinder in vivo accuracy. This application addresses such challenges to fulfill
the elusive aim of absolute MR thermometry using novel multinuclear thermometry developed by the
investigators. Initial results suggest significantly heightened immunity to B0 drift, susceptibility, and pH, and
higher SNR per-unit time, relative to MRS approaches. These developments support an unprecedented level of
overall accuracy, and in this application we apply this approach towards development of absolute 3D whole-
brain thermometry for detection and characterization of ischemic cerebral hyperthermia.

Public health relevance
PROJECT NARRATIVE Cerebral hyperthermia following brain injury occurs commonly, and often precedes significant changes in systemic temperatures. Minimal changes in brain temperature promote rapid deterioration in ischemic brain and produce severely worsened outcomes. Non-invasive means to measure pathologic brain temperature gradients are lacking and hence the need for prognostic biomarkers and treatment targets for dangerous cerebral hyperthermia remains unmet. Magnetic Resonance (MR) thermometry is a promising technique for non-invasive thermometry; this application introduces novel multinuclear thermometry approaches developed by the investigators, exhibiting unprecedented accuracy and performance for direct cerebral thermometry.